DCR IS REQUESTING THE SERVICES OF LEIDOS BIOMEDICAL RESEARCH, INC. TO INITIATE MANAGEMENT, OVERSIGHT, EXECUTION, CLOSEOUT AND PUBLICATION OF FINDINGS

The base of this funding will support an overall framework to allow NIAID to exercise up to 13 options for studies dealing with emerging and re-emerging Infectious Diseases that may include COVID-19.